Role of IKK-beta/NF-kappaB in hypothalamic dysregulation of energy balance

DESCRIPTION (provided by applicant): The hypothalamus critically controls body weight and energy homeostasis. The Insulin and leptin pathways are most pivotal in the hypothalamic regulation of energy balance and therefore critical in the prevention against excessive energy accumulation and the associated obesity and type 2 diabetes (T2D). Recent advances show that persistent overnutrition induces hypothalamic insensitivity to insulin and leptin;however, the involved molecular basis remains unclear. Following our previous discovery that pro-inflammatory nuclear transcription factor NF-kB and its upstream activator IKKβ are activated in peripheral tissues by overnutrition leading to local insulin resistance, this proposal will investigate the role of IKKb/NF-kB in the hypothalamic dysregulation of energy balance, and in particular, in relation to the loss of insulin and leptin sensitivity in the hypothalamus. Preliminary results show that a high-fat diet activates IKKβ/NF-kB in mouse hypothalamus, while activation of IKKb/NF-kB induces hypothalamic insulin resistance. Animal tests further show that activation of IKKβ/NF-kB in the mediobasal hypothalamus (MBH) induced weight gain, while the ablation of IKKβ in a subtype of insulin/leptin-sensitive hypothalamic neurons protected against the dietary induction of obesity. Therefore, this proposal hypothesizes that chronic overnutrition activates IKKβ/NF-kB in the hypothalamus, desensitizes hypothalamic neurons to insulin and leptin, and causes energy imbalance leading to obesity-T2D. This hypothesis predicts that suppressing hypothalamic IKKb could reverse these diseases. The 3 specific aims which will be pursued are as follows: (1) depict the effect of overnutrition on NF-kB in the insulin/leptin- sensitive MBH neurons;(2) study the role of IKKβ/NF-kB on hypothalamic insulin and leptin resistance;(3) assess the metabolic outcomes of ablating IKKβ site-specifically in the MBH neurons or cell-specifically in the most relevant subtypes of insulin/leptin sensitive neurons - AGRP and POMC neurons. To achieve these aims, a series of our established mouse models and approaches of site-directed gene manipulations will be empoyed to analyze NF-kB, insulin/leptin signaling, and the metabolic phenotypes. The completion of this study will advance our knowledge about the brain pathogenesis of obesity-T2D, provide a molecular basis for developing new therapeutic and preventive strategies, and also establish a new model to study the nutrition- inflammation axis in the brain underlying nutritional diseases. PUBLIC HEALTH RELEVANCE: Given the understanding that the promotion of obesity and type 2 diabetes (T2D) by overnutrition critically arises from the overnutrition-impaired brain regulation of energy balance, this project will investigate whether overnutrition triggers a pro-inflammatory pathway in the regulation center of the brain, leading to the regulatory insensitivity that promotes obesity-T2D, and whether suppressing this pathway could reverse or prevent both diseases. The successful completion of this project will be the very first to establish a molecular connection between overnutrition and the inflammation that underlies the brain control of obesity-T2D, and it will also provide new strategies to counteract these diseases by suppressing this inflammatory pathway in the brain.

Public health relevance
NARRATIVE Given the understanding that the promotion of obesity and type 2 diabetes (T2D) by overnutrition critically arises from the overnutrition-impaired brain regulation of energy balance, this project will investigate whether overnutrition triggers a pro-inflammatory pathway in the regulation center of the brain, leading to the regulatory insensitivity that promotes obesity-T2D, and whether suppressing this pathway could reverse or prevent both diseases. The successful completion of this project will be the very first to establish a molecular connection between overnutrition and the inflammation that underlies the brain control of obesity-T2D, and it will also provide new strategies to counteract these diseases by suppressing this inflammatory pathway in the brain.